Spatial and temporal mapping of cell fate within lymphoid tissue

Summary: Spectacular recent advances in single cell genomics have provided high-resolution information
about cell identity, however relating molecular information to the spatial and temporal context remains a
major challenge. This is particularly relevant for the immune system, since immune responses occur in
highly organized tissue environments, and involve tightly-controlled changes in cell state over time. Here
we propose to develop new approaches to increase the spatial and temporal resolution of single cell
analyses, and to use these methods to generate and then disseminate a 4-dimensional (time and 3D
spatial coordinates) map of T cell development and the associated microenvironment in the thymus. In
Aim 1, we will use simultaneous measurement of mRNA and surface proteins on single cells, together with
computation and experimental approaches to develop a temporal map of cell state transitions during T cell
development in the thymus. In Aim 2, we will use coherent Raman and multiphoton microscopy of living
thymic tissue slices, together with laser microdissection, to isolate functionally relevant regions of tissues.
We will then perform single cell analyses of individual cells within these defined regions and use
computational analyses to define cell types and resolve cellular cross-talk. In Aim 3, we will increase the
value of this resource to the scientific community, we will make the data readily accessible to researchers
via a user-friendly interface.
!

Public health relevance
5/14/2019 R24rev 042519 - Google Docs Narrative: We propose to develop an accessible high-resolution map of T cell development within lymphoid tissue that incorporates simultaneous measurements of mRNA and surface proteins, as well as spatial information about the location of individual cells within lymphoid tissues. https://docs.google.com/document/d/1_oSwBBQ337VeESg2j8dqZgAF5sJxKiJ4SQFyn4u7QQE/edit 3/30